STUDY OF ORAL CCII IN TREATMENT OF ACTIVE RHEUMATOID ARTHRITIS

To compare clinical response to graded oral doses of caw to placebo in patients with active rheumatoid arthritis, to determine onset, magnitude and duration of beneficial clinical response, and to determine safety and tolerability of doses and duration of treatment in patient population.